Shared Resources Management

SHARED RESOURES MANAGEMENT – ABSTRACT
The mission of the University of Hawai‘i Cancer Center (UHCC) is to “reduce the burden of cancer through
research, education, patient care and community outreach with an emphasis on the unique cultural and
environmental characteristics of Hawai‘i and the Pacific”. This mission encompasses research on the
underlying biological, social and behavioral causes of cancer incidence, mortality and health outcomes, and on
the strategies and treatments to address them. Availability of and access to resources for laboratory analysis,
data acquisition, study design, and data analysis are essential for this undertaking. However, few of these
services are readily available in Hawai‘i due to its small size and geographic isolation. Therefore, it is crucial
that UHCC provides these essential services locally. Shared Resources (SRs) were established at the UHCC
to address this mission by providing the necessary expertise, equipment, and services. Specifically, the SRs
meet the needs of the research endeavors of the Cancer Biology and Population Sciences in the Pacific
Programs. The Shared Resources proposed for support from the CCSG include 4 existing SRs, namely,
Analytical Biochemistry, Biostatistics, Genomics and Bioinformatics, and Nutrition Support, and one
developing SR, the Body Composition Lab. The goal of the Shared Resource Management is to ensure that
the UHCC Shared Resources align with the institution’s mission by meeting the needs of the researchers,
providing equal access to all UHCC researchers, running cost-effectively, and offering quality state-of-the-art
products. The Shared Resource Management is administered through the Associate Director for Shared
Resources and implemented through the Shared Resource Directors. The SR Directors meet regularly to
share updates and solicit feedback. The Shared Resources are additionally guided and reviewed by an
Oversight Committee of UH faculty members. The SR directors and staff participate in community outreach
and engagement (COE), cancer research training (CRT). The Specific Aims of the Shared Resources are: 1)
Provide research support through scientific expertise and technology to the UH Cancer Center Members, 2)
Evaluate the usage, satisfaction levels, and need for current and potential new services offered through the
UHCC Shared Resources, and 3) Contribute to the training of investigators, staff, and students in research
tools and technologies that will enhance their research endeavors.